Exploring the Genomic Dark Matter of Neurodevelopmental Disorders

SUMMARY
Neurodevelopmental disorders (NDDs) comprise of a group of disorders associated with abnormal brain
development. NDDs with intellectual disability (ID), characterized by significant limitations in intellectual
functioning and adaptive behavior, affect 1% of the population globally and pose a significant public health
burden on society. The underlying neuronal mechanisms of dysregulation that trigger NDD onset and
progression are not fully understood. Rare genetic variants have been shown to play a key role in their
development, especially in those NDDs which are severe in nature. During the last decade, genetic testing has
emerged as an important etiological diagnostic test for NDDs with a considerable impact on disease
management and treatment. Yet, current genetic testing has a diagnostic rate of ~ 50%. Due to technical
limitations in modern next-generation sequencing techniques, these techniques fail to asses a large part of the
genome (2/3rd), missing critical regions which may have clinical significance. New methods now have emerged
that can assess these regions (i.e. the genomic dark matter) better, can access repetitive regions and identify
complex structural genomic events with more accuracy.
As such, we hypothesize that a large fraction of genetic variation involved in the etiology of NDDs remains
undetected by current sequencing techniques. It is imperative to characterize the spectrum of genomic variants
that remain undetected in NDDs to improve diagnostic detection methods. Our goal is two adopt two new cost-
effective technologies, i.e. Optical Genome Mapping (OGM) and Single Tube Long Fragment Reads sequencing
(stLFR), to identify the underlying genetic cause in 50 genetically unsolved families with severe NDDs including
ID. These families were previously investigated using standard short-read sequencing technologies with
inconclusive results. Combining both stLFR and OGM will provide an enhanced overview of genomic variation
in difficult to diagnose cases, including clinically significant genomic variation. This project is a pilot project aimed
to better understand the genomic landscape of variants associated with aberrant neurodevelopment and
cognition. Our current understanding of the human genome is still limited due to restrictions in technologies, and
these results will lay the foundation for a larger scale study which will eventually improve genetic diagnostic
screening and patient management.

Public health relevance
PROJECT NARRATIVE Our proposal seeks to evaluate the full genomic landscape of neurodevelopmental disorders with intellectual disability. We will employ and integrate novel genomic technologies, including optical genome mapping and artificial long read sequencing, to perform a comprehensive investigation of the human genome in parent-child trios which remained genetically unsolved after standard genomic approaches.